Rapid Free-Breathing 3D High-Resolution MRI for Volumetric Liver Iron Quantification

Project Summary
Motivation: In the United States, approximately 1 in 300 non-Hispanic Caucasians have hereditary
hemochromatosis with varying rates in other ethnicities and races. Transfusion hemosiderosis often develops in
cancer patients who have received repeated blood transfusions for cancer-related anemia treatment. Iron
overload, if left untreated, can cause fatal organ damage. Treatment of iron overload aims at reducing body iron
stores with phlebotomy or chelation therapy to maintain sufficiently low body iron levels while minimizing adverse
effects. Liver iron concentration is widely accepted for the best indicator of total body iron stores; therefore,
accurate liver iron quantification improves clinical management of iron overload and minimizes side effects of
chelator administration. MRI-based R2* relaxometry (R2*-MRI) is a noninvasive clinical standard for liver iron
quantification with no ionizing radiation due to its sensitivity to the presence of tissue iron. R2*-MRI acquires
images at multiple time points to estimate R2* (= 1/T2*) relaxation rates at each voxel. However, clinically
available R2*-MRI is prone to patient movement such as respiratory motion that breath-holding is commonly
practiced during scan. Breath-holding is challenging for children and some adults, and unsatisfactory breath-
holding leads to poor R2* values. The other challenge with the current R2*-MRI is caused by signal loss due to
rapid T2* decay in the presence of a high concentration of iron. Severe iron loading is commonly seen in patients
with transfusion-induced iron overload, and the current R2*-MRI does not reliably capture such a rapid signal
decay, resulting in inaccuracy in R2* measurements. This project addresses these challenges to provide novel
R2*-MRI methods for accurate and consistent liver iron quantification.
Approach: The project has two development aims that are validated on clinical studies. Aim 1 will enable rapid
free-breathing ultrashort TE MRI, which acquires images at multiple time points for R2* measurements. Such
acquisition is achieved by incorporating a 3D center-out k-space trajectory with multiple data readouts with self-
navigator without scan time overhead, facilitating parallel imaging compressed sensing. Aim 2 will enable
retrospectively motion-corrected image reconstruction that makes use of a low-rank tensor structure of the
acquired 3D spatiotemporal volumetric data. We will develop strategies for data parallelism and distributed
computing for computationally demanding tensor-based multidimensional reconstruction. Aim 3 will determine
the performance of the innovations in a clinical setting.
Significance: This work will lead to rapid, robust, free-breathing abdominal MRI for more accurate assessment
of liver iron overload in children and adults. The techniques will facilitate widespread application in quantitative
body imaging.

Public health relevance
Project Narrative The accuracy of conventionally available R2*-MRI for liver iron quantification is negatively affected by patient motion and a high concentration of iron as commonly seen in patients with transfusion-induced iron overload. Accurate liver iron quantification is critical for managing iron overload and evaluating the efficacy of chelation treatment aimed at reducing body iron stores while minimizing adverse effects of chelator administration. This project will develop a rapid, motion-tolerant, and free-breathing abdominal R2*-MRI method, providing high- resolution volumetric liver R2* images for accurate iron quantification.